Native-like Envelope Trimer Therapeutic Vaccination for Induction of Broadly Neutralizing Antibodies to Facilitate HIV Functional Cure

PROJECT SUMMARY
Passively transferred broadly neutralizing antibodies (bnAbs) are being evaluated in clinical trials for HIV-1
treatment and prevention. The results of these studies in macaques and humans suggest that bnAbs have
antiviral activity and possibly a “vaccinal” effect, i.e. induction of HIV-specific cellular immune responses. After
several years of infection, approximately 5-15% of HIV-1 infected individuals develop some ability to cross-
neutralize a broad range of heterologous viral strains, with only 1% of individuals developing potent bnAbs. It is
possible that individuals with chronic HIV-1 infection have elicited precursors of HIV bnAbs, but that these
responses have been stunted by viral escape or by affinity maturation away from highly conserved epitopes. If
HIV bnAb precursors have indeed been elicited in these individuals as our preliminary data indicates, then such
responses could be boosted by delivery of native-like HIV-1 envelope (Env) trimers. Development of therapies
that may induce bnAb in vivo would be a valuable advance for both HIV-1 treatment and prevention. We
conducted neutralization assays with curated virus panels that are particularly sensitive to VRC01-class
precursor antibodies, V2 apex-precursors and PGT 121 precursor antibodies and demonstrated that the baseline
frequencies of bnAb precursors was ~20% in a small cohort (N = 25) of chronically HIV 1-infected individuals
receiving suppressive ART. We therefore propose to test if bnAbs can be induced by immunization with native-
like Env trimer vaccination in chronic, ART-suppressed HIV-1 infection, including in individuals who have initiated
the appropriate pathways of B-cell somatic hypermutation through natural infection. Native-like trimers mimic the
structure of Env on the surface of the virus largely correctly and display multiple bnAb epitopes in a manner
similar to how these epitopes appear on the virion-associated spike, and can induce autologous primary virus
(Tier-2) responses in animal models .Accordingly, we will conduct a Phase 1, randomized, placebo controlled,
exploratory dose-escalation study evaluating the safety and immunogenicity of a native-like trimer vaccine, VRC-
HIVRGP096-00-VP (Trimer 4571), developed and provided to us by the NIH Vaccine Research Center, in HIV-
1 infected individuals on suppressive ART. We will assess vaccine induced changes in autologous and cross
clade virus neutralization and trimer-specific antibody response. Additionally, we will perform detailed
mechanistic studies to investigate the effect of bnAb precursor presence on bnAb B-cell lineage development,
characterize epitope specificities and assess trimer-induced changes in the B cell repertoire. Using multiple,
state-of-the-art assays, we will measure the effect of the immunogen on the size of the peripheral blood HIV-1
reservoir and potential sieving effect on the residual plasma viremia and cellular HIV Env RNA. Trimer induced
virologic and immunological assessments will provide new insights into the conditions and the benefits of these
neutralizing antibody responses toward achieving sustained HIV-1 remission without ART.

Public health relevance
PROJECT NARRATIVE Specific antibodies that block many strains of HIV are called broadly neutralizing antibodies or bnAbs. Rare people living with HIV (PLWH) develop these antibodies in their blood and others may have early or partially active antibodies. The purpose of this project is to conduct a clinical study of a new vaccine, called Trimer 4571, to determine if the vaccine is safe in PLWH and if it improves the antibody response to HIV. Additionally, the study will see if the vaccine has any impact on the HIV reservoir in blood cells. If successful, this may pave the way toward achieving sustained remission of HIV in the absence of antiretroviral therapy.